Paracrine regulation of islet cell function by primary cilia

Project Summary/Abstract
The primary cilium plays critical roles in cellular signaling which within the pancreatic islets are
essential for the proper regulation of hormone secretion and blood glucose control. In both
humans and rodent models, diabetes manifests from misregulated islet cell secretory function
due to altered crosstalk and coordination among the key endocrine cells, but the etiology of islet
cell paracrine dysregulation in diabetes is unknown. Our recent studies reveal that primary cilia
are required for the maintenance of islet function by allowing islet cells to sense and respond to
each other’s activity status as communicated by hormonal cues. Based on these findings, we
hypothesize that primary cilia promote islet cell coordination by mediating paracrine hormone
signaling via the major α- and β-cell hormones. To these this hypothesis, we will use islet cell-
specific primary cilia deletion mouse models to delineate the mechanisms by which α/β-cell cilia
regulate paracrine hormone release and action on target cells. Aim 1 will determine whether
primary cilia mediate α-cell intra-islet signaling via glucagon and GLP-1. Aim 2 will determine
whether primary cilia mediate β-cell intra-islet signaling via insulin and serotonin. In both aims,
we will employ orthogonal imaging and biochemical approaches in primary islets to delineate a
physiologic role for primary cilia in islet function. A detailed understanding of islet cell inter-
regulation by primary cilia could support the development of novel therapies to treat or prevent
islet failure in diabetes.

Public health relevance
Project Narrative Primary cilia are signaling hubs on the cell surface with demonstrated roles in promoting islet cell coordination and function in diabetes, however the signaling pathways by which cilia mediate islet cell communication have not been elucidated. This proposal aims to identify the intra-islet paracrine regulatory mechanisms by which primary cilia modulate islet cell activity via the major α/β-cell secretory products. Completion of this study will facilitate the identification of new therapeutic targets for preserving islet function and improving glucose control in diabetes.